USE OF GAMMA INTERFERON IN CHRONIC GRANULOMATOUS DISEASE

We are investigating the biochemical, biological and clinical consequences of gamma interferon therapy in chronic granulomatous disease. The patient receives the interferon bi-weekly and to this date has had no significant side effects. Her biochemical abnormality has partially corrected and she is clinical stable.